Protective immunity following dengue virus natural infections and vaccination

SUMMARY (UC BERKELEY, CORE A) The Administrative Core (Core A) will be responsible for coordinating Program Project (PPG or P01) partners by providing an umbrella infrastructure that will manage overall operations. Effective scientific management and coordination by the Administrative Core will give direction, oversight, and quality assurance for each Project and Core's research activities and will maximize collaboration and exchange among all participating members. Core A will achieve this by ensuring a dynamic interaction among all researchers in the Program Project, specifically, by fostering and facilitating the timely exchange of information, necessary reagents and protocols and sharing of data and will assume financial responsibility for the costs associated with these activities. Core A will promote and mediate regular communication and will facilitate the logistics for scheduled meetings, monthly P01-wide teleconferences, and ad hoc calls. It will also be responsible for arranging and facilitating an annual in-person meeting at the UC Berkeley campus where the overall P01 Director, Project 1, Core A, and Core C are headquartered. In addition, Core A will provide fiscal oversight and general administrative, compliance, and budgetary support for the overall Program Project in coordination with all the administrative designees from the partner institutions. Finally, Core A will coordinate reports to the NIH, ensure compliance with NIH and local institutional requirements, and serve as the primary contact between the P01, the NIAID program officer, and other NIAID staff. Thus, Core A plays a central role in ensuring the smooth administrative functioning of the Program Project as a whole.

Public health relevance
RELEVANCE (UC BERKELEY, CORE A) Dengue is a major public health problem worldwide, and it is critical to improve our understanding of the human immune response to dengue virus infection and what elements of immune response are associated with protection from or susceptibility to disease. This Program Project should help define immune correlates of protection and contribute to efforts to successfully develop an effective tetravalent dengue vaccine that confers long-term immunity to all four DENV serotypes. The Administrative Core (Core A) will provide crucial coordination functions to ensure regular and fluid exchange of ideas, data, and reagents between P01 investigators as well as compliance with NIH and local institutional requirements.